A new process to improve the mechanical performance of crosslinked UHMWPE injoint replacement prostheses

While total joint replacement prostheses have been a great success for over 80 years in providing mobility to
patients with osteoarthritis, post-surgery complications like aseptic loosening, dislocation and infections remain
as problems, often leading to costly and complicated revision surgery. The objective of this proposal is to
address implant dislocation, the second most common complication for total hip replacement surgeries. One
solution to reduce the incidence of dislocation is to increase the diameter of the femoral head and accordingly
decrease the thickness of the ultra-high molecular weight polyethylene component. The consequences of
these design changes are that the larger articular surface area could lead to higher volumetric wear and the
thinner polyethylene components are subjected to higher stresses with a greater likelihood for fracture. The
highly wear resistant crosslinked polyethylenes introduced in the late 90’s have addressed the issue of wear
but these crosslinked materials also have lower mechanical toughness, limiting the use of thinner polyethylene
components. To solve this problem, we have developed a patent-protected rapid-pressurization process which
has the potential to greatly increase the ductility of crosslinked polyethylene without compromising its strength.
We hypothesize that pressure-quenching of antioxidant containing crosslinked polyethylene will exceed the
toughness, strength and resistance to fatigue crack propagation over uncrosslinked polyethylene without
compromising wear or oxidation resistance. Our preliminary data on pressure quenching and past research on
thermal quenching show that a pseudo-hydrostatic process in which the melted, crosslinked polyethylene is
rapidly pressurized and crystallized can be performed on large cylinders using a simple hydraulic press, which
is easily translatable into a manufacturing process, providing bulk crosslinked polyethylene from which
implants can be machined. The specific aims of the proposal are: Aim 1 will optimize the pressure-quenching
process of Vitamin E containing crosslinked polyethylene and verify its superior mechanical properties using
tensile, fracture toughness and impact tests. Aim 2 will use accelerating aging to demonstrate that the
pressure-quenched Vitamin E containing crosslinked polyethylene is oxidation-resistant. Aim 3 will include
long-term wear and fatigue crack propagation tests to verify that pressure-quenched, Vitamin E containing
crosslinked polyethylene preserves wear resistance and has a higher resistance to fatigue crack propagation.
This proposal has the potential to guide in the fabrication of total hip replacement components which are less
likely to dislocate, without compromising either wear resistance or risk for mechanical damage. Furthermore,
knee and shoulder joint components, which are subjected to higher stresses could be better protected from
mechanical damage. The long-term plan is to leverage this materials-formulation study to investigate implant
designs in a larger project that can reduce the incidence of dislocation without compromising either wear or
mechanical damage. Longer lasting joint replacements would greatly benefit the elderly with osteoarthritis who
require these implants for mobility.

Public health relevance
The second most common complication following total hip replacement surgery is dislocation affecting up to 11% of patients undergoing primary total hip arthroplasty and as high as 25% for patients undergoing revision total hip arthroplasty. The primary objective of this research is to optimize a rapid-pressurization process that, for the first time, enable the development of implant designs that greatly reduce the incidence of dislocation, thereby reducing the need for additional surgical procedures for the elderly with arthritis who require hip replacements for mobility.